Mechanisms of Gonococcal Pilin Antigenic and Phase Variation

Abstract for the MERIT Extension Period (June 2016) The pathogenic Neisseria are obligate human pathogens that rely on several antigenic variation systems to continually colonize and cause disease in the human population. This proposal will continue our studies into the molecular mechanisms used to promote pilin antigenic variation in Neisseria gonorrhoeae. High frequency changes in the pilin amino acid sequence are mediated by gene conversion reactions between one of 18 silent pilin copies and the single expressed pilin gene. In the next funding period we will continue to conduct our field-leading investigations into the molecular mechanisms require to effect high frequency gene conversion within the context of a bacterial chromosome. The results of these innovative studies will have great impact on the study of Neisserial pathogenesis, mechanisms of antigenic variation, DNA recombination and replication, and the role of alternative DNA structures on molecular processes in all cells.

Public health relevance
Project Narrative The CDC has listed Neisseria gonorrhoeae as an urgent level pathogen given its rapid development of antibiotic resistance, ease of spreading the infection, and ability to cause serious health complications, such as infertility, ectopic pregnancy, and potentially endocarditis and neurological problems. N. gonorrhoeae express surface fibers called Type IV pili that are crucial for pathogenesis, and the level of expression is regulated by a complex recombination system called antigenic variation. Through antigenic variation, cells can express different levels of piliation and, through an unknown mechanism, show different levels of sensitivity to the immune system; the purpose of the proposed research is to determine how N. gonorrhoeae piliation impacts resistance to the human innate immune system.